Longitudinal study of metal mixtures and the developmental origins of adolescent risk-taking

Abstract
Risk-taking is a critical component of adolescence, yet maladaptive or unhealthy risk-taking during this
developmental period is associated with significant adolescent morbidity and mortality. While research has
linked early-life environmental exposures to maladaptive neurobehavioral phenotypes, little is known about the
developmental trajectories that contribute to risk-taking. Because brain development is dynamic and nonlinear
throughout adolescence, research needs to assess phenotypic developmental trajectories over time rather
than at a single timepoint—however, such research is challenging, time-intensive, and costly. We can
overcome these challenges with our Programming Research in Obesity, GRowth, Environment and Social
Stressors (PROGRESS) cohort, which has collected longitudinal data on metal exposures as well as neural
and behavioral outcomes from pregnancy through childhood and into adolescence. In our first grant cycle, we
linked reconstructed early-life metal exposure data from our novel tooth biomarker with a single timepoint of
multi-modal magnetic resonance imaging (MRI) scans and neuropsychological assessments to demonstrate
that a mixture of lead, manganese, and zinc exposure at 6–9 postnatal months increased internalizing
behaviors and impacted neural activity in brain areas subserving emotional processing in preadolescent
children. Increased internalizing problems in childhood may increase the risk for maladaptive risk-taking
behaviors in adolescence. Thus, we hypothesize that early-life exposure to neuroactive metals may impact the
trajectory of brain and behavioral development related to risk-taking. In this first renewal application, we
propose to extend our study in the PROGRESS cohort to include longitudinal assessments of brain structure
and function, allowing us to investigate the impact of early-life metal exposures on developmental trajectories
of adolescent risk-taking behaviors. We propose an accelerated longitudinal design to shorten the time needed
to assess neurodevelopmental trajectories compared to a traditional longitudinal cohort. Our design leverages
existing baseline multi-modal MRI and performative assessments of risk-taking collected in the first cycle (ages
8–14) and adds follow-up of these assessments in the new cycle. We also will enroll new PROGRESS
participants (ages 16–22), allowing us to assess phenotypic trajectories from age 8–22 years—thus covering
all of adolescence. For all participants, we will collect self-reported assessments of risk-taking behavior in
adolescence. This renewal builds on our prior cross-sectional and prospective findings by creating a lifecourse
study of adolescent developmental trajectories of brain structure/function and risk-taking spanning more than
20 years in a single grant cycle. Our approach will serve as a model for future studies of early-life environment
and adolescent health, an understudied life stage representing the transition into adulthood. We will determine
critical windows for early-life metal exposures on adolescent developmental trajectories of risk-taking, which
are key to applying interventions at the appropriate age to promote optimal development and improved health.

Public health relevance
Narrative Risk-taking is a hallmark characteristic of adolescence; while risk-taking is an essential component of evolutionary survival and experiential learning, maladaptive or irrational risk-taking in adolescence is associated with significant morbidity and mortality. During this critical life stage, profound brain remodeling and behavioral development may be influenced by early-life environmental exposures, affecting developmental trajectories related to risk-taking, yet such research is challenging, time-intensive, and costly to perform. We will leverage an ongoing cohort study to assess the impact of early-life metal exposures on developmental trajectories of adolescent risk-taking behaviors spanning more than 20 years, critical research needed to understand risk-taking behaviors and inform effective and timely interventions to promote optimal adolescent development.